Recombinant hANGPTL4 and CKD

Abstract
Despite decades of treatment with ACE inhibitors and Angiotensin II receptor blockers, and the
recent addition of SGLT2 inhibitors, chronic kidney disease (CKD) patients continue to progress
towards end stage kidney disease. While studying mechanisms of proteinuria and kidney
disease a decade ago, we identified and published circulating sialylated Angiopoietin-like-4
(ANGPTL4) and mutated versions of the human protein as a potential therapy to reduce
proteinuria via interaction with glomerular integrins. Subsequent studies (preliminary data in this
proposal) have now shown that transgene secreted rat ANGPTL4 and the mutated human
ANGPTL4 protein 8520 reduce the progression of CKD in rat models of focal and segmental
glomerulosclerosis (FSGS)and diabetic nephropathy (DN), respectively. Moreover, the
preservation of inulin clearance glomerular filtration rate (GFR) in diabetic rats treated with 8520
was superior to control treated rats, and 8520 + ACE inhibitors superior to control treated rats or
rats treated with ACE inhibitors alone. We further noted that 8520 treatment reduces kidney
interstitial capillary apoptosis significantly, thereby also reducing interstitial fibrosis, potentially
via interaction with integrins.
In this proposal, we plan to extend our mechanistic studies on the beneficial interaction of 8520
with integrins in kidney interstitial capillaries, while also extending potential therapeutic studies
in rat models of DN and FSGS, that include comparisons with ACE inhibitors and SGLT2
inhibitors, and additional vital sign monitoring using telemetry. Finally, we study potential
therapeutic effects of 8520 in a large animal (minipig) model of CKD.
In Aim 1, 8520 efficacy in improving CKD will be studied in ZSF1 diabetic rats and Buffalo Mna
(FSGS) rats, including comparisons and combinations with ACE inhibitors, SGLT2 inhibitors and
controls.
In Aim 2, we will study whether the anti-apoptosis effects of 8520 on kidney interstitial capillaries
are mediated via Integrin β1 or Integrin β5. Additional Mass Spectrometry studies on purified
8520 will be conducted to develop an assay to monitor plasma levels, and an ELISA to study
potential immune response to mutations in 8520 will be developed.
In Aim 3, the autologous phase of nephrotoxic nephritis will be studied in minipigs to determine
the efficacy of 8520 in slowing the progression of CKD in a large animal model.

Public health relevance
Project narrative Recombinant mutated human Angiopoietin-like 4 protein will be investigated for its potential role in reducing or eliminating the progression of chronic kidney disease in rat and minpig models. Anti-apoptosis mechanisms that maintain interstitial capillary endothelium integrity and keep repair vessels open to reduce interstitial fibrosis will be investigated in endothelial Integrin knockout mouse models.